Administrative Supplement: Adverse childhood experiences and alcohol misuse in Latino adolescents

Project Summary
The purpose of this K supplement is to request support following the impending critical life event of childbirth.
I was awarded an NIAAA K08 in February 2022, had my first child in June 2022, and then gave birth to my
second child in March 2024. The K08 aims are to 1) identify risk and protective factors in the ACEs-alcohol use
link, 2) evaluate the role of HPA axis functioning (hair cortisol) in the ACEs-alcohol misuse link and identify
relevant protective factors and 3) explore epigenetic mechanisms (saliva DNA methylation) linking ACEs and
HPA axis functioning. Despite becoming a first-time mother shortly after I was awarded a K08 grant, I
maintained a high level of productivity, which included completing all biological and survey data collection in the
first year. NIAAA’s administrative supplement following the birth of my first child allowed me to maintain a very
high level of productivity at a more sustainable pace, given that I was able to fund a full-time clinical research
coordinator and part-time biostatistician for support. It is worth noting that with the full-time clinical research
coordinator’s help, I was able to revise and resubmit a first-author manuscript and submit two additional first-
author manuscripts during my maternity leave while simultaneously caring for myself and my infant. Therefore,
the purpose of this K08 supplement application is to request funding to support my full-time clinical research
coordinator and fund a part-time biostatistician. The clinical research coordinator and biostatistician will support
me in my next career phase: submitting my first R34 and R01 grants, and transitioning to research
independence.

Public health relevance
Project Narrative Following the impending critical life event of childbirth, the purpose of my K supplement application is to request funding to continue supporting a full-time clinical research coordinator and a part-time biostatistician. The clinical research coordinator and biostatistician will assist me with literature review, managing IRB submissions, drafting research-related documentation, data management, data analysis, and supporting grant submissions.